High speed and wearable speckle contrast optical spectroscopy for cuffless blood pressure measurements

Project Summary:
Hypertension is the leading cause of cardiovascular disease (CVD) and affects nearly half of adults in the US.
Periodic cuff-based blood pressure (BP) measurements with a sphygmomanometer are the predominant method
of monitoring BP, but have been shown to be a poor reflection of a person’s usual BP. Conversely, ambulatory
blood pressure monitoring (ABPM), in which patients wear a BP cuff on their arm for 24 hours while
measurements are recorded every 30-60 minutes, more accurately predicts future CVD. Unfortunately, ABPM
is cumbersome and uncomfortable for patients, preventing its widespread adoption. In addition, ABPM devices
often disrupt sleep, thereby affecting nocturnal BP, leading to potentially biased estimates of CVD risk. A cuffless
and non-invasive ABPM would facilitate greater patient access and more frequent BP measurements, potentially
transforming the management of hypertensive patients. We have recently demonstrated that high-speed (390
Hz) speckle contrast optical spectroscopy (SCOS) can provide accurate cuff-less BP measurements in healthy
subjects during exercise. SCOS utilizes speckle-based measurements to measure blood flow in tissue. Our
preliminary results have shown that the addition of blood flow index (BFi) information improves BP estimation
significantly, reducing errors within the Association for the Advancement of Medical Instrumentation (AAMI)
standards. While promising, the technology must be converted from its current benchtop state to a wearable
device capable of multi-hour ambulatory monitoring. Additionally, the technique needs to be tested in a wider
range of subjects, including those with hypertension. To tackle these challenges, our team will develop the first
high speed wearable SCOS system with FPGA-based real-time processing to achieve extraction of BFi and
photoplethysmography (PPG) cardiac signals on the wrist and finger (Aim 1). We will embed two small (3.7 X 3
mm) 180 Hz CMOS detectors with high pixel density (640 X 480), and the unit will be battery operated and
designed for long-term (8 hour) real-world measurements. Simultaneously, we will validate SCOS for cuffless
blood pressure monitoring in patients with hypertension (Aim 2). We will measure N = 50 patients with elevated
BP using our benchtop SCOS system during an isometric hand grip exercise and develop subject-specific
machine learning models to predict BP. Finally, we will validate wearable SCOS for cuffless ABPM (Aim 3). First,
N=20 healthy volunteers will be measured during various motions to establish artifact removal algorithms. Then,
hypertensive subjects (N=50) will be measured during a continuous 2 hr measurement that includes a positional
test and a handgrip exercise test. Then, to more rigorously test the wearable SCOS device in the real-world, an
additional cohort of N = 35 healthy volunteers will be assessed for 8 hr during their normal daily activities. Finally,
N=10 subjects will be measured during vigorous exercise. If successful, this project will provide a new highly
accurate and continuous ABPM methodology that is far less disruptive to patients, thus improving access to
ABPM for hypertension management.

Public health relevance
PROJECT NARRATIVE This research proposal centers on the creation and validation of a novel, non-invasive, wearable optical measurement technique for estimating blood pressure without the need for a cuff. Emphasizing both technological advancement and clinical viability, the proposal envisions the potential use of this innovative technology in the management of confirmed or suspected hypertension. In practice, the developed measurement technique would enable physicians to non-disruptively monitor patients throughout their daily routines and during sleep, offering a superior means to assess future cardiovascular disease risk.